OXYRADICAL STRESS MARKERS DURING ONSET/RESOLUTION OF BRONCHOPULMONARY DYSPLASIA

The purpose of this study is to define the role of alveolar inflammation in the pathogenesis of bronchopulmonary dysplasia (BPD), in particular the effect of various polymorphonuclear leukocytes constituents on the epithelial lining fluid inflammatory repertoire. This study attempts to correlate changes in patient clinical status during the development of BPD with alterations in tracheal aspirate fluid biochemical markers obtained from these neonates.